The Impact of APOL1 Copy Number Variation on Kidney Disease Susceptibility in African Americans

Project Summary
African Americans are three to four times more likely to develop kidney failure than other populations.
Coding variants in Apolipoprotein L1 (APOL1), termed G1 and G2, drive nondiabetic kidney disease risk in this
population. Previous functional studies demonstrated that the APOL1 risk variants promote lysosomal
dysfunction, cell death, and numerous kidney injury phenotypes in mouse models. While disease risk typically
occurs in a recessive fashion, heterozygous risk variant carriers can develop kidney disease, and not all
individuals carrying the risk variants develop disease, highlighting our incomplete understanding of the APOL1
genetic susceptibility to kidney disease in African Americans.
The Pollak Lab identified a 101kb duplication encompassing APOL1 and postulated that APOL1 copy
number variations (CNVs) contribute to the phenotypic heterogeneity of APOL1-associated kidney diseases.
Inheriting additional alleles of APOL1 increases the risk of kidney disease. More recent data suggest there
have been additional duplication events, and the structure and consequences of the CNVs remain unexplored.
APOL1 CNVs harboring various non-risk or risk variant copies illustrates an additional complexity to APOL1-
mediated disease susceptibility. We hypothesize there are APOL1 CNVs with duplicated risk variant
combinations that mediate disease risk through increased risk allele expression, thereby driving cell death.
This proposal will explore the importance of CNVs for kidney disease by: 1) developing a computational
approach to characterize the risk variant architecture of APOL1 CNVs (how many non-risk and risk variants
present in an APOL1 CNV carrier) and identify risk variant combinations in patients with nondiabetic kidney
diseases, and 2) determining the in vitro functional consequences of harboring APOL1 CNVs through
investigations of allelic dosage mechanisms and cell death upon interferon treatment. Preliminary examination
of whole genome sequencing data from 1000Genomes APOL1 CNV carriers shows that utilizing CNV region
and allelic read depths will facilitate duplicated risk variant determination. This proposed work will advance our
knowledge of the APOL1 genetic susceptibility to nondiabetic kidney diseases and aid in kidney disease risk
assessment for individuals carrying APOL1 risk alleles and CNVs.
Beth Israel Deaconess Medical Center (BIDMC), a Harvard Medical School affiliated institution,
provides an exceptional learning environment for conducting this proposed research. Fellowship training will
include obtaining computational skills for studying structural variations, genomic allelic discrimination of the
APOL1 risk variants in CNVs, transcriptomic analyses for analyzing allelic dosage, and wet-lab techniques for
functional investigation of APOL1 CNVs. Mentorship from investigators at BIDMC who are leaders in APOL1
genetics and nondiabetic kidney diseases, in addition to collaborations from members at the Broad Institute,
will create a foundation for achieving academic career goals of becoming a principal investigator.

Public health relevance
Project Narrative Copy number variations (CNVs) of Apolipoprotein L1 (APOL1) are associated with nondiabetic kidney diseases, albeit the allelic architecture of the APOL1 kidney disease risk variants within CNVs remains unclear. Our studies aim to discriminate the non-risk and risk variant copies within APOL1 CNVs and determine the functional consequences of APOL1 CNVs. This research will provide insights into risk variant dosage mechanisms of APOL1 CNVs as a driver for the phenotypic variability observed in APOL1-associated nondiabetic kidney diseases in African Americans.